Generation and manipulation of combinatorial connectivity in olfactory perception

ABSTRACT
The central problem addressed by this proposal is how the brain represents almost limitless objects to “catego-
rize an unlabeled world” (Edelman, 1976). This problem is particularly acute in olfaction, because physical odor
signals are not obviously dimensional. While instinctual meanings are imparted through the structure of neural
circuits, learning mechanisms can theoretically select experience-relevant representations from circuits lacking
a priori structure. By analogy, the vertebrate adaptive immune system defends against novel invaders by se-
lectively amplifying B cells carrying strongly binding antibodies from a randomly produced pool. How unstruc-
tured, combinatorial connectivity forms during development is not understood in any system. The numerical
complexity of vertebrate olfactory cortex and other associative learning centers including the cerebellum, hip-
pocampus, and entorhinal cortex complicates developmental studies. Instead, we propose to address this
question in the numerically simplified olfactory learning center of arthropods, the mushroom body. While this
brain area performs a function similar to the cortex or cerebellum, representing objects as combinations of sen-
sory stimuli, the fruit fly mushroom body has only 2000 intrinsic neurons. These intrinsic Kenyon cells receive
3-10 olfactory inputs, with each cell receiving different inputs. The sets of inputs to individual Kenyon cells are
unpredictable—knowing one input to a particular cell does not illuminate which other inputs that cell receives.
To ask how unstructured connectivity pattern forms during development, we are first using a variety of tech-
niques to manipulate the ratio between Kenyon cells and their incoming olfactory inputs in order to identify
mechanisms that set the number of inputs to individual Kenyon cells. Second, we are testing whether variation
in expression of cell surface molecules across pre- and post-synaptic cells allows variation in connectivity be-
tween them. The quantitative complexity and density of sensory inputs to associative brain areas are theorized
to “optimize” representations of sensory objects, with alterations in these patterns expected to degrade neural
and behavioral distinctions among stimuli. If successful, we will produce a model of the developmental mecha-
nisms that generate neurons responding to complex sensory stimuli that can be applied to studying develop-
ment and organization of sensory inputs to vertebrate associative learning areas; this study will also create
techniques to manipulate the wiring parameters of the Drosophila mushroom body to explicitly test how wiring
parameters dictate stimulus representation and separation, and how their alteration alters perception and
learning.

Public health relevance
NARRATIVE Animals interpret complex sensory environments using both instinct and memories of past experiences. In- stinctual odor processing occurs in a region of the brain where the inborn structure of connections among neurons generates meaning, while learned processing occurs in a separate brain area where unstructured neuronal connections gain meaning through experience This project explores how neurons make unpre- dictable connections with one another during the development of an olfactory learning center in the fruit fly brain.